Enhancing Diversity through IHSAN (Interdisciplinary Health disparities and data Science trAiNing) Extension

The RCMI Coordinating Center (RCMI-CC) is uniquely positioned to enhance data
science capacity and foster collaborations throughout the RCMI Consortium. The RCMI-
CC serves as the central coordination hub for RCMI U54 centers and engages PI/PDs
and Core Directors for research infrastructure, investigator development, and community
engagement to spur cross-institutional mentoring and investigator development, inter-
institutional collaborations, partnerships and resource sharing. This supplement seeks
to build on our experience developing and implementing a coordinated RCMI Data
Science Initiative to upskill RCMI investigators in data science, including tools, methods,
and best practices with a focus on reproducible data analysis and effective knowledge
mobilization around health disparities and incentivizing collaborations at the nexus of
data science and health disparities between investigators within and outside of the RCMI
consortium. Our specific aims are: (1) To enhance our Technical Introduction to Data
Science and Health Disparities curriculum by (i) co-creating a Python track
introducing data science principles and techniques with an emphasis on health disparity
research and (ii) integrating additional NIH-funded resources and datasets, including the
National COVID Cohort Collaborative (N3C), (2) To enhance the sustainability of our
Data Science and Health Disparities training program by developing an evidence-
based virtual collaboratory to support synchronous and asynchronous peer, coach, and
domain expert interactions to develop collaborative research projects across U54
centers as well as between U54 and non-RCMI institutions, (3) To scale access to Data
Science and Health Disparities curriculum and training program by recording
workshops and producing a Massive Open Online Course (MOOC) for asynchronous,
on-demand learning.

Public health relevance
This supplement seeks to build on our experience developing and implementing a coordinated RCMI Data Science Initiative to upskill RCMI investigators in data science, including tools, methods, and best practices with a focus on reproducible data analysis and effective knowledge mobilization around health disparities and incentivizing collaborations at the nexus of data science and health disparities between investigators within and outside of the RCMI consortium.